Coordinated Microstimulation of Sacral Afferent Pathways to Control Continence and Micturition Reflexes

Abstract
The loss of normal bladder control that occurs after a spinal cord injury can lead to severe health consequences.
In fact, the most common reason for hospitalization in people with spinal cord injuries is urinary tract
complications that arise from deficiencies in the current clinical methods to manage bladder function. In addition,
social issues surrounding regular bladder care can lead to a decrease in quality of life and surveys indicate that
people with spinal cord injury desire improvements in bladder care above many other functions. Several
promising approaches to improve bladder function using neurotechnologies have been proposed, however all
but a few techniques have failed to reach clinical use. A fundamental limitation with previous approaches is that
they have not been able to selectively or simultaneously stimulate the distributed reflex pathways known to
contribute to normal function. For example, stimulation of different sensory pathways in the pudendal nerve can
elicit both continence and micturition reflexes, however, these reflexes are modulated by sensory activity in the
pelvic nerve. Accessing all these pathways in the peripheral nervous systems is extremely challenging.
The goal of this proposal is to achieve selective activation of afferent pathways from the bladder, urethra and
genitalia by implanting multielectrode arrays into the sacral dorsal root ganglia (DRG). At this interface location,
we believe that sensory afferents from both the pudendal and pelvic nerves can be stimulated selectively without
activating motor pathways. Using this approach, we plan to independently modulate activity in multiple reflex
pathways to the spinal cord and will assess the effect on control of continence and micturition. Specifically, these
experiments propose to 1) determine the patterns of afferent recruitment in response to sacral DRG
microstimulation, 2) test the effects of single-channel and coordinated multichannel microstimulation of sacral
DRG afferents on recruitment of storage and voiding reflexes, and 3) determine the impact of supraspinal reflex
pathways on coordinated multichannel microstimulation. Success in these aims will demonstrate that the sacral
DRG can be used to enable access to the distributed peripheral pathways of the lower urinary tract. This access
could be useful for both fundamental investigations into the neural control of the bladder as well as for
development of neuroprosthetic technologies. Ultimately, our long-term goal is to develop a device that leverages
knowledge of the spinal control of continence and micturition reflexes to restore functionally normal control of
the bladder to people living with injured spinal cords.

Public health relevance
Project Narrative Nearly everyone with a spinal cord injury suffers from impaired bladder control that can lead to serious medical complications. Individuals living with spinal cord injuries have expressed a significant desire to have better treatment options available and numerous attempts to develop electrical stimulation devices to manage bladder function have been explored, yet few viable options currently exist. This proposal will investigate the ability of high-density arrays of microelectrodes implanted in the spinal nerves to enable bladder storage and voiding functions by selectively stimulating spinal cord reflex pathways involved in normal and impaired bladder control.